EVALUTION OF PULMONARY COMPLICATIONS IN OBESE CHILDREN

We performed polysomnography, multiple sleep latency testing and pulmonary function testing in 12 obese children and adolescents without presenting symptoms of obstructive sleep apnea syndrome. Six subjects (50%) had abnormal polysomnograms, 4 of which were clinically significant. No child showed evidence of restrictive lung disease. We conclude that obstructive sleep apnea syndrome occurs commonly in obese children and adolescents.